PHASE II THERAPEUTIC TRIAL OF DEXTROMETHORPHAN VS PLACEBO IN ALS

Mounting evidence implicates glutamate and the process of excitotoxicity in the pathogenesis of ALS. In this study, we are looking at the effect of Dextromethorphan - a selective antagonist of the NMDA subtype of the glutamate receptor-on ALS. This is a phase II, double blind, placebo controlled study to be carried out over a three year period with a target enrollment of 60 patients.